Mechanisms of acute kidney injury in malaria - Resubmission - 1

Summary
Acute kidney injury (AKI) is one of the least understood but most common complications of severe pediatric
malaria and is strongly associated with increased mortality. Our previous results indicate that elevated levels of
autoimmune antibodies circulating in children with severe falciparum malaria strongly correlate with
parameters of kidney dysfunction. These results suggest that the pathogenesis of malaria-induced AKI could
be similar to classical autoimmune diseases such as systemic lupus erythematosus, where autoimmune
antibodies form immune complexes (IC) that induce kidney pathology. However, our previous work has also
identified that markers of hemolysis (free-heme and hemoglobin), correlate with the development of AKI in
African children. Hemolysis is a well-established cause of kidney injury, suggesting that lysis of erythrocytes
induced by autoimmune antibodies may also contribute to AKI.
Our overarching hypothesis is that autoimmune antibodies decisively contribute to kidney pathology in
malaria. We intend to determine the relative contribution to malaria-induce kidney pathology of two possible
autoantibody-induced mechanisms: (1) deposition of IC and (2) hemolysis-induced damage in the kidneys.
Using mice models of malaria, we will test this hypothesis and determine the role of autoantibodies in kidney
pathology. We will characterize whether IC deposition in the kidneys (aim 1.1) and/or hemolysis mediated by
autoimmune antibodies (aim 1.2) are major causes of AKI during acute malaria. We will also test the role of
neutrophil extracellular traps (NETs) in the formation of DNA-IC and in kidney dysfunction during malaria.
In aim 2 we will characterize the relationship of autoantibodies and IC with hemolysis by analyzing the relation
of the heme-axis (free-heme, hemopexin and cell-free hemoglobin, previously proposed to contribute to AKI in
malaria), oxidative stress and nitric oxide bioavailability, with acute and persistent kidney dysfunction during
malaria in a clinically well-characterized prospective cohort of 600 children with severe malaria followed for one
year.
This study will increase our understanding of kidney dysfunction in malaria both mechanistically and
epidemiologically, paving the way for the finding of new biomarkers and the development of therapies.

Public health relevance
Narrative Malaria frequently causes acute kidney injury in patients, which contributes significantly to death by this disease, but the mechanisms underlying this complication remain largely unknown. We have found that high levels of autoimmune antibodies in the plasma of malaria patients strongly correlate with kidney disfunction. We intend to use mice models and malaria patient samples to investigate whether autoimmune antibodies actually cause kidney disfunction and what are the mechanisms mediating this pathology.